Data Collection and Transcription

Objective. Core B has three goals: to recruit participants for each of the four projects; to collect data for each of the four projects; and to transcribe the speech and gesture data gathered in Projects I, II and III.